BUSINESS ANALYST SUPPORT SERVICES FOR THE NCI, OFFICE OF SCIENTIFIC OPERATIONS, AT THE FREDERICK NATIONAL LABORATORY FOR CANCER RESEARCH (FNLCR), A FEDERALLY FUNDED RESEARCH AND DEVELOPMENT CENTER (FF

Support services for the NCI, Office of Scientific Operations at the Frederick National Laboratory for Cancer Research, a Federally Funded Research and Development Center.